Defining human and mouse non-canonical inflammasome responses to LPS

Project Summary
Gram-negative bacterial infections cause more than 325,000 cases of severe sepsis in the US and almost 10
million cases worldwide annually, with a >30% mortality rate. Gram-negative bacterial sepsis is caused by a
dysregulated systemic inflammatory response to lipopolysaccharide (LPS) that is sensed at the plasma
membrane by Toll Like Receptor 4 (TLR4) and in the cytosol by caspase-11 (CASP11) in mice, and its orthologs
caspases-4 and -5 (CASP4 and CASP5) in humans. CASP11, CASP4, and CASP5 oligomerize into non-
canonical inflammasomes in response to LPS, leading to pyroptotic cell death and release of inflammatory
mediators. While excessive CASP11 activation during systemic LPS delivery or bacteremia can lead to sepsis,
CASP11 is also essential for anti-bacterial defense against gram-negative bacterial infections in mouse models.
Bacterial pathogens can vary the acylation status of LPS to evade innate immune sensing by TLR4 and CASP11.
Intriguingly, recent findings by us and others indicate that human CASP4/5 are activated by LPS structures that
are not sensed by TLR4 and CASP11, indicating that humans have evolved to respond to a broader repertoire
of LPS structures than mice. The mechanisms dictating the differential responsiveness of CASP11 and CASP4/5
to distinct alterations in LPS structure and the consequences for host defense and sepsis are poorly understood.
Thus, we propose to define the molecular and cellular mechanisms of non-canonical inflammasome responses
to LPS in mice and humans using a combination of in vitro and in vivo models. This fundamental information will
provide essential insight for the development of improved therapeutics that effectively reduce human sepsis, as
well as immune adjuvants that improve host responses to immunoevasive bacterial pathogens.

Public health relevance
Project Narrative Inflammasomes are critical for host defense against bacteria, but an overwhelming response can lead to sepsis. These studies will provide fundamental insight into how inflammasome responses to bacterial LPS are differentially regulated in humans and mice. This knowledge will provide a foundation for the development of more effective anti-sepsis therapies and novel immune adjuvants.